Pathologic tau and dendritic spine loss in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT Alzheimer’s disease (AD) is the leading cause of dementia in adults over the age of 65, and currently affects approximately 5.8 million people in the United States. As the population ages, this number is expected to rise to 13.8 million by the year 2050. Thus, there is a need for progress in the understanding of AD etiology, as well as in development of effective therapeutics. AD is characterized by aggregates of amyloid-β (Aβ) and of the microtubule-associated protein tau, and the extent of tau pathology spread throughout the brain correlates with both synapse loss and the severity of cognitive impairment. The goal of this proposal is to test the hypothesis that accumulation of phosphorylated tau in synaptic compartments contributes to spine loss in AD. Aim 1 will determine if postsynaptic accumulation of phosphorylated tau precedes dendritic spine loss in AD. Aim 2 will determine if trans-synaptic spread of pathologic tau is dependent on expression of the cellular prion protein (PrPC) in dendritic spines. PrPC is involved in Aβ- and tau-induced deficits in synaptic plasticity, and has been explored as an Aβ-relevant therapeutic. However, this proposal will be the first to test the ability of blocking PrPC to halt tau hyperphosphorylation and propagation, both critical events in AD pathogenesis. These aims will be achieved through both microscopy and biochemical approaches in a tauopathy mouse model and in neuronal culture systems. Overall, findings from the proposed project will inform on the role of pathologic tau in dendritic spine loss and uncover mechanisms of synaptic tau accumulation and trans-synaptic propagation.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is the most common cause of dementia in people over the age of 65 and is the 6th leading cause of death in the United States. Despite this, the pathological mechanisms underlying Alzheimer’s disease remain unknown, and there are no efficacious treatment options or preventative measures. In this proposal, I will further the understanding of both the role of tau in Alzheimer’s disease pathogenesis and the role of the cellular prion protein in tau propagation and synaptic accumulation, findings which will help refine tau-based therapeutics.